Essential role of Stasimon in motor circuit development and disease

Motor circuits control fundamental behaviors such as swallowing, breathing and locomotion. Spinal motor
neurons are the key mediators translating motor commands generated within the central nervous system to
peripheral muscle targets. Motor neurons are activated by a precisely regulated pattern of synaptic activity from
sensory neurons, local spinal interneurons and descending pathways from the brain. Additionally, synaptic
activity received by motor neurons during early development shapes their functional properties. In contrast, gene
mutations that induce perturbations in either neuronal wiring or synaptic drive received by motor neurons often
result in motor system disorders, although the primary cellular targets and the precise molecular events remain
largely elusive. Thus, understanding the principles of neural circuit development and function as well as the
mechanisms of synaptic dysfunction and selective neuronal death in human disease represent outstanding
challenges in neurobiology. A prominent example of this situation is spinal muscular atrophy (SMA)—an inherited
neuromuscular disease caused by ubiquitous deficiency in the survival motor neuron (SMN) protein. SMA
pathogenesis involves alterations of multiple components of the motor circuit leading to abnormalities in spinal
reflexes, motor neuron loss and skeletal muscle atrophy. However, the molecular and cellular mechanisms
underlying motor circuit dysfunction in SMA remain poorly understood. In our previous work we have identified
Stasimon as a novel transmembrane protein that localizes at contacts sites between ER and mitochondria
membranes and contributes to motor dysfunction in animal models of SMA through undefined mechanisms.
Furthermore, our preliminary studies revealed that Stasimon’s conditional depletion in neural circuits severely
disrupts motor function in mouse models, pointing to an essential requirement for normal motor system
development and function. Building on these findings, our goal is to define the neural circuit components and
cellular pathway(s) in which Stasimon functions that underlie its essential role in the motor circuit and contribution
to human disease. To do so, we will employ newly developed conditional mice for cell type-­specific restoration
of Stasimon in vivo to study whether Stasimon dysfunction induced by SMN deficiency acts cell autonomously
to promote death of SMA motor neurons and non-­cell autonomously to alter motor neuron firing through
dysfunction of proprioceptive sensory neurons (Aim 1). We will also investigate the temporal and spatial
requirement of Stasimon for normal development and function of the sensory-­motor circuit using novel
conditional knockout mice we have recently developed (Aim 2). Lastly, we will use both cellular and mouse
models to characterize the molecular function of Stasimon at the ER-­mitochondria contacts and its requirement
for motor circuit function in health and disease (Aim 3). The successful accomplishment of the objectives of this
proposal will characterize novel aspects of synaptic transmission and motor circuit function as well as the
underlying mechanisms of SMA.

Public health relevance
Neuronal control of movement is extensively studied not only because it underlies fundamental human behaviors but also because diseases that affect the motor system represent a significant burden for human health. Stasimon is an ER--resident transmembrane protein with an important yet molecularly undefined role in health and disease of the motor system. This proposal describes a multidisciplinary effort aimed to establish the essential requirement of Stasimon for motor function and its contribution to the neurodegenerative disease SMA at the molecular, cellular and circuit levels.